CORE--DIAGNOSTIC METHODS AND CASE REGISTRY CORE

This Core B has primary responsibility for coordination and tracking of subjects for the Program Project investigations it Core B also has responsibility for acquisition of data collected during induction, for entry of this data into the Program Project Database/Data Archives, and for scheduling and tracking the progress of data acquisition and analysis in general across all projects. This Core is organized into a set of service- based subcores which provide cost-efficient and centralized resource services-based subcores which provide cost-efficient an centralized resource services to the five Projects. The subcores are as follows: (1) Induction/Screening Subcore will perform the screening of all human subjects to the Program Project, which includes gathering of medical, behavioral, and background records relevant to induction and application of inclusionary/exclusionary criteria; (2) Behavioral Diagnostics Subcore will be responsible for acquisition and analysis of behavioral data associated with induciton, including standardized tests of intelligence for matching and measures of affective functioning and home environment for matching and application of inclusionary/exclusionary criteria; (3) Neuroimaging/ERP Subcore will be responsible for coordinating the acquisition of ERP and MRI data for Project II and Project III studies; (4) Brain Autopsy Subcore will coordinate brain removal, tissue acquisition for genetic analyses (in coordination with Genetic Samples Subcore and Project III), brain fixation, MRI (in coordination with Neuroimaging Subcore and Project II), and transport to the Project IV experimental laboratory for detailed cytoarchitectonic analysis; (5) Genetic Samples Subcore will obtain blood samples from all WMS subjects and their parents, enter pertinent information about the sample donors to the database and assign a pseudonym, mail the blood sample for transformation and storage, and transmit data and DNA samples to Project V. Across all subcores, Core B will be responsible for organizing an efficient schedule of subject interaction with Program Project personnel, allowing for collection of all necessary data. It will also track data after collection and processing to ensure timely and accurate entry to the Project Database/Data Archives, and to ensure efficient flow of data among Projects and between projects and cores.